Circuit-level substrates of ASD-related cognitive and behavioral impairments

Project Summary

A goal of basic mental health research is to understand the molecular, cellular and circuit level substrates that
contribute to neuropsychiatric disorders. The goal of this project is to better understand the principles
underlying circuit dysfunction associated with cognitive and social impairments common to these disorders. A
promising approach to better understand these substrates is to perform in-­depth studies in animal models with
high construct and face validities. De novo pathogenic SYNGAP1 mutations leading to haploinsufficiency
cause one the most common genetically defined and non-­inherited forms of intellectual disability (ID) with
autism spectrum disorder (ASD;? termed MRD5;? OMIN# 612621). Studies supported by the first budget period
identified Syngap1 heterozygous KO mice as an outstanding genetic model of ASD with ID. Using this model,
we discovered a developmental sensitive period of Syngap1 function that promotes the proper function of
cortical networks. The neurobiological studies we published in the last period were significant because they
identified the developmental timing of dendrite and spine maturation selectivity within forebrain excitatory
neurons as a critical substrate that shapes brain function relevant to cognitive and social development.

For this competitive renewal, we will build on our discoveries in the first budget period by studying the key
substrates of circuit dysfunction in the Syngap1 model by probing how this gene regulates cortical sensory
processing relevant to cognition and learning. This approach is significant because sensory impairments are
extremely common in ASD/ID and these impairments influence behavioral adaptations, including learning.
Syngap1 patients express sensory abnormalities related to touch and pain. However, the circuit abnormalities
that underlie sensory dysfunction are unclear. Thus, our approach is innovative because studies will be
performed in the mouse somatosensory cortex, which will enable powerful in vivo experiments that are capable
of directly linking cellular-­ and circuit-­level functional impairments to sensory-­based learning and behavioral
abnormalities. The first Aim will investigate the cellular mechanisms underlying impaired somatosensory cortex
network function caused by pathogenic Syngap1 mutations, with an emphasis on how network-­level E/I
imbalances emerge within cortical circuits that directly encode sensory representations. Research proposed in
the second Aim will determine the cellular mechanisms that contribute to sensory-­driven learning impairments
in Syngap1 mice. The impact of these studies is that they are expected to advance our understanding how
cortical circuit dysfunction leads to behavioral impairments associated with ASD/ID.

Public health relevance
NARRATIVE ASD and ID reflect dysfunction of developing neural circuits that drive impaired behavior and cognition. The cellular mechanisms that cause circuit dysfunction remain unclear; thus, this project Aims to discover novel circuit-level substrates that may explain the origins of behavioral and cognitive abnormalities associated with these neuropsychiatric disorders. The knowledge gained from these studies is expected to help direct improved therapeutic approaches to treat impaired cognitive and behavioral impairments common to ASD and ID.